HLA class I peptidome diversities and CD8+ T cell responses to COVID-19 vaccines

CD8+ T cells recognize short peptide antigens in the context of major histocompatibility complex class I (MHC-
I) proteins. Three sets of genes, the human leukocyte antigens (HLA) HLA-A, HLA-B and HLA-C encode the
heavy chains of human MHC-I (HLA-I) proteins, which also contain a light chain (β2-microglobulin) and a
peptide. The HLA-A, HLA-B and HLA-C genes are highly polymorphic. In cells, individual HLA-I allotypes can
bind to many peptides derived from intracellular proteins. Cell infection induces the binding of specific
pathogen-derived peptides, which can trigger CD8+ T cell recognition and immunity. Recent mass
spectrometric (MS) studies have identified the sequences of thousands of peptides that bind to HLA-I
allotypes, the individual peptidomes. Inspections of these peptide sequences lead to the hypothesis of variable
peptide repertoire sizes among HLA-I allotypes and resulting variations in the breadth of CD8+ T cell responses
to SARS-Cov2 infection and COVID-19 vaccination. To address this hypothesis, in the proposed studies,
quantitative high resolution mass spectrometry (MS) will be used to measure differences in self-peptide
repertoire sizes for selected HLA-B allotypes. Factors that underlie variations in repertoire sizes will be
examined. Additionally, the breadth of SARS-CoV-2 Spike epitopes that induce CD8+ T cell activation will be
measured using blood from select HLA genotyped blood donors who have been vaccinated against COVID-19,
examining the prevalence of epitope breadth variations among HLA-I allotypes. Taken together, these studies
address the prevalence and consequences of variable HLA-I peptidome diversities, with a focus on immunity
induced by COVID-19 vaccines. The knowledge resulting from these studies will inform on key aspects of HLA-
I biology and vaccine-indued immunity.

Public health relevance
HLA-I molecules are mediators of protective immune responses via an immune cell subset called cytotoxic T cells, which recognize and kill virus-infected cells. HLA-I molecules are highly variable, with an individual person expressing only up to six of thousands of variants that exist in the human population. In this project, we seek to understand how specific variants of HLA-I proteins influence the breadth of cytotoxic T cell-dependent immune responses induced by COVID-19 vaccinations.